Identification of Novel Mutations In Pediatric Cancers

The human genome project has identified categorized and sequenced most of the 30,000 or so human genes. Recently the ability to perform massively parallel sequencing of the whole genome has increased with the development of next generation and single molecule sequencers. It is speculated that withing the next 2-5yrs it will be possible to sequence whole human genomes for under $1000. Through collaborative networks my lab has archived greater than 600 clinically annotated neuroblastoma, and greater than 100 rhabdomyosarcoma tumor samples. By bioinformatic techniques we are identifying all know targets in neuroblastoma and rhabdomyosarcoma. We are using microarray and other genomic methods to isolate relevant portions of the neuroblastoma genome and sequence greater than 200 genes in greater than 100 samples in a pilot experiment. Our goal is to identify activating mutations that can be targeted for therapy in patients with high risk neuroblastoma and rhabdomyosarcoma for which there is no currently available therapy.